Identifying adjunctive therapy in the experimental model of malaria to improve cerebral malaria outcomes

ABSTRACT
Malaria remains a great public health challenge that has resisted worldwide control efforts. Some individuals
who are infected with Plasmodium falciparum develop cerebral malaria (CM), which is associated with high
morbidity and mortality despite the use of antimalarial therapy. To date, no effective adjunctive therapy is
available. As brain swelling was recently identified as the main cause of death in CM, we propose to test dimethyl
fumarate (DMF) to modulate neuroinflammation in an experimental cerebral malaria mouse model using
histopathological and neuroimaging techniques to define its mechanisms of protection. The preliminary data
demonstrate that DMF provides a survival advantage in ECM. Importantly, DMF is FDA-approved for other
neuroinflammatory conditions and thus could potentially be repurposed for CM. Our long-term goal is to identify
potential adjunctive therapies that reduce brain swelling and increase survival in a pre-clinical model to provide
a foundation for future clinical trials and ultimately improve the outcomes of CM.

Public health relevance
NARRATIVE This project will study the effect of therapeutic drugs to lessen the rate of death and neurologic disability that can occur in cerebral malaria a severe complication of Plasmodium infection. We will test therapeutics in the animal model of malaria and target the brain pathology that can occur during infection. These studies may provide the pre-clinical data to allow future clinical studies in humans to improve health outcomes in severe malaria.